Interdisciplinary Graduate Program in Type 1 Diabetes and Biomedical Engineering

The incidence of type 1 diabetes (T1D) remains on the rise in the U.S. and around the world. Fortunately,
individuals with the disease are now living longer, largely due to dramatic improvements in technology-based
disease management strategies such as continuous glucose monitors, insulin pumps, and algorithms allowing
for their integration into what is now known as an “artificial pancreas.” However, the vast majority of T1D patients
still experience difficulty in achieving clinical glycemic targets and as result, develop organ, nerve and vascular
damage over time. Additionally, to many, the cost of T1D management presents a substantial financial burden,
and the prevalence of clinical depression and anxiety disorders is disproportionately high in persons living with
a T1D diagnosis. As such, there is a continuing, if not urgent need for innovative therapeutics and technologies
to further advance not only T1D care but in addition, progress towards a means to prevent or reverse the disease.
This, in turn, forms the need to train a generation of scientists who simultaneously have in-depth knowledge of
T1D etiopathogenesis (including expertise in systems immunology, human pancreatic and islet cell biology), and
also can contribute to the materials, tissue, and cellular engineering of such interventions. The overall objective
of our Interdisciplinary Graduate Program in T1D and Biomedical Engineering is to provide an integrated and
highly collaborative training experience; this, to develop pre-doctoral students into graduates having skillsets and
knowledge vital for careers that bridge these two important disciplines. Pre-doctoral candidates select co-
mentors (one T1D and one Biomedical Engineering) from a diverse faculty with research interests spanning: 1)
Immunology/Genetics (autoimmunity, eQTL and genotype/phenotype analysis, innate immunity, gene editing, T
cell engineering); 2) Stem Cell Biology/Therapeutics (cell therapy, iPSC generation, cell scaffolds); 3) Disease
Modeling (live pancreas slice culture, islet-immune chip, animal models); 4) Biostatistics/Bioinformatics; and 5)
Clinical/Translational Research (clinical trials, therapeutic development, behavioral research, clinical
psychology). This training infrastructure is further enhanced by the university’s NIH supported CTSI as well as
Institutes and Centers directed by faculty members affiliated with this training program. The training program is
largely preceptorial, with more than 75% of the trainee’s time devoted to independent research activities and the
remainder spent in formal courses and conferences. Training is focused on disease-oriented research with a
curriculum tailored to each trainee’s individual needs. To date, a concerted effort has also been extended to
rigorous program evaluation, fostering trainee career development, and recruitment of underrepresented
minority (URM), disability, and female candidates. Trainees emanating from this program have been highly
successful in terms of research publications, acquisition of independent funding through F31 awards, and
subsequent career development. We believe this program will continue to produce graduates who are uniquely
poised to address a vital societal need to improve the lives of those with and at risk for T1D.

Public health relevance
PROJECT NARRATIVE A number of transformative advances have recently occurred at the intersection of type 1 diabetes (T1D) and biomedical engineering (BME), including the development of technology-based strategies for disease management as well as progress towards the first T1D immunotherapy, an effort currently under review by United States Food and Drug Administration (FDA). To address the rapidly growing need for individuals cross-trained in these arenas, we established this interdisciplinary graduate program to facilitate co-mentoring of pre-doctoral students in BME and T1D. Given our program’s 100% retention of graduates in science careers to date, alongside prioritization to those with underrepresented minority or disability designations, we are confident that the training environment supported by this T32 will continue to prepare the next generation of researchers for careers seeking to develop new strategies for the management, prevention and reversal of T1D.